Polarity Signals Coordinate Neuronal Migration and Germinal Zone Exit

During neural development, billions of neurons differentiate, migrate, send out axons, and synapse onto their targets in a precisely choreographed sequence. Acquisition of neuronal polarity by progenitor cells or newborn neurons drives many early morphogenetic processes including the exit of these cells from germinal niches, migration initiation to a final laminar position or axon-dendrite specification during neural circuit formation. Despite the discovery of polarity pathways acting concurrently with differentiation, it's unclear how neurons traverse complex polarity transitions or how neuronal progenitors control the onset of polarization during development. Identifying such mechanisms can advance our understanding of neuronal migration disorders as well as diseases like pediatric cancers where germinal zone (GZ) exit is compromised. My laboratory uses the Partitioning Defective or Pard, cell polarity signaling complex as a model to understand the molecular and cellular mechanisms controlling cerebellar granule neuron (CGN) neuronal differentiation, polarization, and migration in the developing cerebellum. Our previous work examining the cell biological underpinning of CGN development illustrates that Pard complex signaling regulates multiple events that are coincident with CGN differentiation including GZ exit, radial migration initiation, neuronal adhesion to migration substrates and the cadence of nucleokinesis. In the previous funding cycle of this grant, we investigated how Pard complex activity is regulated during CGN differentiation. We identified a novel mechanism where the mRNA expression of the Pard6α and Pard3 Pard complex components is excluded from granule neuron progenitors (GNPs) by the Zeb1 transcriptional repressor. Necessity-sufficiency and epistasis analysis using ex vivo cell biological approaches show that Zeb1 controls GZ exit, neurite extension and radial migration initiation in a Pard6α and Pard3 dependent fashion. We will expand on our preliminary studies by examining how Zeb1 controls GZ occupancy and is regulated by extrinsic GZ conditions with these Aims: Aim1. Determine how Zeb1 and Pard6α control GNP GZ occupancy through Itgβ1 adhesion. Aim2: Determine how the EGLN1-VHL-Hif1α pathway controls CGN differentiation and polarization via Zeb1. These studies will address two important questions in the developing brain: 1) What are the adhesive mechanisms that maintain GZ occupancy of progenitors cells and how they are attenuated as polarization proceeds during differentiation? Investigating this question will provide insight into the GZ exit defects that frequently accompany pediatric cancer. 2) How do environmental conditions like oxygen tension control the maturation of progenitor cells and differentiating neurons? Investigating this question will provide insight into how defective oxygen homeostasis associated with pre-term birth or perinatal hypoxia perturbs neural development.

Public health relevance
During neural development, the maturation of nerve cells drives fundamental cellular processes that assemble neuronal circuitry. This proposal studies the mechanismsgoverning the cell biology of neuronal differentiation and how environmental cues like oxygen tension facilitate maturation. The imaging tools and conceptual advances developed by this proposal will not only expand our knowledge of neural development but could lead to new diagnostics and treatments for neurodevelopmental disorders, such as pediatric cancers or developmental defects associated with pre- term birth.